Sense4Safety: Supporting socially vulnerable older adults

Abstract Falls and fall-related injuries are significant public health issues for adults 65 years of age and older. Over a third of older adults (OA) fall each year and 10-20% of falls result in serious injuries such as fractures and head trauma. The annual direct medical costs in the US as a result of falls are estimated to exceed $50 billion, and this estimate does not include the indirect costs of disability, dependence, and decreased quality of life. This project targets community dwelling OA with mild cognitive impairment (MCI) who are socially vulnerable. MCI is a leading risk factor for falls in OA. Approximately 15%-20% of OA have MCI, and over 60% of OA with MCI fall annually — two to three times the rate of those without cognitive impairment. Socially vulnerable OA living in low-resource neighborhoods with poor housing conditions have twice the risk of falling. We have developed an innovative technology-supported nursing-driven intervention called Sense4Safety to 1) identify escalating risk for falls real-time through in-home passive sensor monitoring (including depth and motion sensors); 2) employ machine learning to inform individualized alerts for fall risk; and 3) link `at risk' socially vulnerable older adults with a nurse tele-coach who will guide them in implementing evidence-based individualized plans to reduce fall-risk. The purpose of this study is to refine the Sense4Safety intervention based on extensive feedback by low income OA with MCI, their family members or trusted others and clinicians in order to ensure that the passive monitoring system to predict fall risk for OA with MCI can generate actionable and tailored information that can be used effectively by these stakeholder groups.

Public health relevance
Project Narrative The proposed research study aims to refine an innovative technology-supported nursing-driven intervention called Sense4Safety to 1) identify escalating risk for falls real-time through in-home passive sensor monitoring (including depth and motion sensors); 2) employ machine learning to inform individualized alerts for fall risk; and 3) link `at risk' socially vulnerable older adults with a nurse tele-coach who will guide them in implementing evidence-based individualized plans to reduce fall-risk. Falls are a significant public health issue for older adults and critical for seniors in low income settings; therefore, the study is highly relevant to public health.